CSR&D Research Career Scientist Award Application

SUMMARY
Dr. Haghighi’s research specialty is in medical epigenetics with applications to traumatic brain Injury (TBI) and
suicidal behavior. These epigenetic studies involve how genes are differentially transcribed and regulated,
within human clinical and postmortem brain samples, providing a snapshot of potential transcriptional
regulatory abnormalities associated with disease progression and neuropathology. Dr. Haghighi’s clinical
studies show how environmental exposure affects the epigenome. Specifically, in her studies of blast
exposures and related injuries and neurotrauma, she investigates how response to repeated blast-exposure
induces molecular perturbations including long-term transcriptional regulatory changes that result in symptoms
of sleep disturbances, anxiety, cognitive deficits and depression and PTSD. As our Veterans with TBI are at
greater risk of suicide, Dr. Haghighi has developed a complementary research program focusing on
neuroinflammatory & epigenetic mechanisms in suicidal behavior. This is because environmental exposures
such as TBI and other injuries during military service significantly contribute to suicide risk and are associated
with increased inflammation. As such, Dr. Haghighi’s research program is highly impactful in bringing a greater
understanding into the etiological basis for the risk of suicide, towards improved clinical care of our Veterans.

Public health relevance
NARRATIVE Dr. Haghighi’s genomics research focuses on how environmental signals or insults are interpreted by the genome through epigenetics. Epigenetics is the bridge connecting the environment and genetics, regulating gene expression and cellular response to environmental cues throughout our lifespan. Specifically, she is interested in how physical and/or psychosocial stress throughout the lifespan can induce epigenetic abnormalities leading to neuropathological and psychiatric symptoms. Using human studies, she investigates the role of such stressors using genomic approaches to identify the underlying molecular mechanisms in such disorders. Her successes in building productive collaborations within the VA, DoD, and academia to support her TBI and suicide genomics research programs demonstrates Dr. Haghighi’s continued leadership capabilities in building a strong suicide clinical and research program.